IGF::OT::IGF BIOINFORMATICS SUPPORT FOR THE NIEHS IN DIR & DNTP

The purpose of this contract is to provide support to researchers in the Divisions of National Toxicology Program (DNTP) and the Intramural Research program at the NIEHS. Sciome, LLC is the contractor providing bioinformatic support services and is based in Research Triangle Park, NC. Large amounts of data are produced at NIEHS of varying size and complexity in fields of toxicology, genomics, transcriptomics, high throughput screening and data extraction from diverse text sources. Bioinformatic analysis is needed to support interpretation and use of this data in research and program activities at DNTP and DIR.